Investigating SCN8A developmental and epileptic encephalopathy mechanisms and treatments in a human cellular model of the thalamocortical circuit

PROJECT SUMMARY/ABSTRACT
Mutations in the voltage-gated sodium channel (VGSC) gene, SCN8A, are associated with
developmental and epileptic encephalopathy (DEE). DEE is a severe condition, characterized by
neurodevelopmental delay, behavioral and intellectual impairment, and seizures. Despite the availability of
several VGSC-targeting pharmacological agents, no effective treatment exists for patients with SCN8A-DEE.
Additionally, seizure-altering medication rarely ameliorates DEE-associated cognitive and behavioral
comorbidities. To better understand the etiology of SCN8A-DEE and to test novel gene therapy approaches as
alternatives to pharmacological interventions, I have generated a novel human induced pluripotent stem cell
(hiPSC)-derived organoid model of the thalamocortical circuit (hTCO). This human cellular thalamocortical
system produces rhythmic oscillations that resemble those that are affected in animal models of Scn8a-
associated epilepsy. Here, I will interrogate the underlying physiology of altered thalamocortical cellular and
network activity using whole-cell patch-clamp and two-photon calcium imaging techniques, as well as
immunohistochemical and transcriptomic analysis of control and SCN8A-DEE mutant hTCOs. My preliminary
work has already established that cells required for thalamocortical rhythm generation are present in hTCOs and
that hTCOs exhibit mature thalamocortical-like network activity. Using this model, I will test the hypothesis that
SCN8A-DEE hTCOs demonstrate hypersynchronous oscillatory activity and delayed neural maturation in
comparison to control hTCOs. In addition to assessing circuit physiology, I will also examine the effects of two
SCN8A-targeted gene therapies on neuronal and network physiology in SCN8A-DEE and control hTCOs. The
first approach uses short hairpin RNAs (shRNAs) to knockdown SCN8A gene expression in order to reduce the
amount of hyperactive mutant SCN8A within neurons. The second approach involves the use of a novel peptide
that interacts with the intracellular inactivation gate to reduce SCN8A-DEE-associated increased persistent
sodium current. This study will provide valuable training opportunities for me to learn cutting-edge approaches
while I interrogate the mechanisms that lead to SCN8A-DEE. Exploration of SCN8A-DEE pathogenesis and
examinations of genetic therapeutic efficacy to treat SCN8A-DEE pathologies in a construct-valid, human cellular
model system have strong potential to yield insights into SCN8A-DEE and improve the quality of life for patients
living with genetic epilepsies.

Public health relevance
PROJECT NARRATIVE Developmental and epileptic encephalopathy (DEE) is a severe and complex disease characterized by neurodevelopmental delay, behavioral and intellectual impairment, and seizures. Mutations in the voltage-gated sodium channel (VGSC) gene, SCN8A, can cause DEE. This proposed work will use a novel human cellular model of a part of the nervous system that is impaired in SCN8A-DEE to understand how the disease affects brain function and to test novel therapeutic approaches.